Training At-Risk Industrial, Telecommunication and Immigrant Workers to Assess and Improve their Health and Safety Conditions: Training At-Risk Workers on the Corona Virus and Bio-Safety Hazards

SUMMARY The COVID-19 pandemic has highlighted important social disparities contributing to inequitable rates of COVID-19 disease and death across racial and ethnic minority and low-income working populations. These COVID-19 related disparities result from a confluence of risks, including differences in the racial and ethnic patterns of workers who must work outside of their homes, as well as inequalities in overall economic and living conditions, including dense housing, poor access to health services, food insecurity and disparities in rates of chronic disease. The Steelworkers Charitable and Educational Organization/Tony Mazzocchi Center (SCEO/TMC), in conjunction with community-based organizations (CBOs) in both the New York/New Jersey (NY/NJ) metropolitan region and in the Anniston-Oxford metro area in northeastern Alabama, has created new and expanded existing partnerships that work to address these disparities by providing essential COVID-19 information, training and services to promote local resilience and recovery for low income Latinx and African American workers and their families. In this administrative supplement, we propose to further fortify and expand these partnerships to support ongoing recovery activities in both the NY/NJ metropolitan region and in the Anniston-Oxford metro area of Alabama through wider dissemination of appropriate public health practices and support services. Project activities will promote community recovery through COVID-19 training interventions, educational outreach, material adaption, and expanded coordination with service providers, public health providers and other emergency support services to extend and deepen reach to underrepresented community members. Project activities will enhance training on job safety, assist with distribution of personal protective equipment, and provide infectious disease guidance and referral to testing and medical care and other essential services; and continue to build ongoing disaster preparedness. We will evaluate and strengthen the ongoing workplace H&S and community recovery programs through cross-program exchange of best practices, lessons learned and training and education outputs and outcomes.

Public health relevance
NARRATIVE The Steelworkers Charitable and Educational Organization/Tony Mazzocchi Center (SCEO/TMC), in conjunction with community-based organizations (CBOs) in both the New York/New Jersey (NY/NJ) metropolitan region and in the Anniston-Oxford metro area in northeastern Alabama will supplement ongoing WTP activities to support and expand partnerships with CBO's serving communities disproportionately impacted by COVID-19. Project activities will enhance training on job safety, assist with distribution of personal protective equipment, provide infectious disease guidance and referral to testing and medical care and other essential services, and continue to build ongoing disaster preparedness.